Early life respiratory viral infections shape immune development trajectories

Abstract
Viral respiratory infections are responsible for major morbidity and mortality in early life. Infants account for a
significant proportion of influenza hospitalizations and are considered a top high-risk group. In addition to the
acute morbidity, initial immune responses to influenza shape/imprint the immune system and affect subsequent
responses to influenza infections and vaccinations, which tend to induce humoral responses skewed towards
epitopes present in the first influenza antigen encountered. In contrast, SARS-CoV-2 infection in infants is
generally mild and less severe than in older individuals. This is remarkable and suggests that there are unique
features on how the infant immune system responds to SARS-CoV-2, compared to its responses against other
respiratory viruses, that can be leveraged to improve our understanding of early life immunity.
On the basis of these observations, we hypothesize that early life viral respiratory infections elicit virus-specific
immune responses that lead to distinct immune developmental trajectories. To address this hypothesis, we will
compare three longitudinal cohorts: i) infants infected with SARS-CoV-2; ii) infants infected with influenza virus;
and as reference iii) healthy infants with none of those two infections. After acute infection children will be
followed longitudinally for three years and immune responses assessed in the context of influenza and COVID-
19 vaccinations.
We designed two integrated research projects, supported by three cores. Project 1 will define: 1) the differences
of blood transcriptional immune signatures in infants with SARS-CoV-2 versus infants with influenza infection;
2) the magnitude, immunodominance pattern and breath of the antibody responses to influenza virus and
evolution of antibody responses to SARS-CoV-2; and 3) perform high-throughput longitudinal evaluation of B
cell responses to influenza and SARS-CoV-2. Project 2 will: 1) Assess the blood cell composition, transcriptome
and epigenome in response to influenza and SARS-CoV-2 infection occurring in the first six months of life at the
single cell level; and 2) Characterize the PBMC phenotype/cell composition, transcriptome and epigenome in
response to vaccination against influenza and SARS-CoV-2.

Public health relevance
Narrative Influenza viruses cause severe disease in infants. In contrast, SARS-CoV-2 infection in infants is generally mild and less severe. This is remarkable and offers a unique opportunity to study how the infant immune system responds to these two viral infections.